Posttraumatic Stress Disorder, Accelerated Biological Aging, and Veteran Health

Posttraumatic stress disorder (PTSD) is a prevalent and costly mental health disorder associated with poorer
health and higher healthcare utilization. These outcomes are a particular concern among Veterans, who have
higher rates of PTSD compared to civilian populations. Veterans with PTSD, for example, are twice as likely to
experience premature death compared to Veterans without PTSD. How might PTSD affect health? Recent
studies have shown that PTSD can accelerate biological aging—i.e., the rate at which people evidence gradual
physiological decline consistent with chronological aging. Accelerated aging is theorized to result in more
disability, disease, and premature death and could explain why Veterans with PTSD are at greater risk of poor
health.
There is great promise in slowing aging to prevent ill health, but methods of assessing biological aging have
been constrained by long and costly data collection, limiting effective application to clinical settings. Recent
methods have shown the potential to use markers of DNA methylation to calculate the speed at which people
are aging using biomarkers collected at a single point in time. This novel methodology could provide the
opportunity to identify and treat Veterans who are at risk of rapid aging—such as those with PTSD—years
before poor health develops. These findings could help promote the importance and uptake of PTSD treatment
among both Veterans and healthcare providers, reducing healthcare costs and human suffering. Doing so,
however, would require applying these methods in Veteran samples and empirically validating this approach.
This Research Plan proposes to examine the links between PTSD, accelerated aging, and later health. The
main hypotheses guiding this work are that Veterans with PTSD will evidence accelerated aging, and this
accelerated aging will be associated with poorer health 5 years later. A further goal will be to test whether
candidate psychosocial characteristics— higher social support, fewer comorbid mental health disorders,
positive health behaviors, and treatment for PTSD—might protect against accelerated aging for Veterans with
PTSD. Specific Aims—Aim 1: Examine whether Veterans with PTSD have accelerated biological aging.
Aim 2: Test whether accelerated biological aging predicts Veterans’ midlife health over the subsequent
5 years. Aim 3: Determine whether candidate psychosocial characteristics are associated with slower
aging and better midlife health for Veterans with PTSD. These aims will be achieved using existing data
from the Post-Deployment Mental Health (PDMH) study, a multi-site cohort of Afghanistan and Iraq era
Veterans. PDMH data, including methylation data used to derived biological aging scores, will be linked to
health outcomes in the VA electronic health record (EHR). This study will help determine whether Veterans
with PTSD have accelerated biological aging compared to Veterans without PTSD, as well as if accelerated
aging predicts poorer Veteran health. This study will provide the first evidence that biological aging explains
how PTSD results in poor Veteran health, as well as what psychosocial characteristics could be targeted by
intervention to slow aging. The results of these aims will be used to support a Merit Review award submission
proposing to examine change in biological aging following behavioral intervention for Veterans with PTSD.
The Training and Mentoring plans outline the professional development, training, and mentorship activities that
will support the applicant’s development as an early-career investigator in the VA. Specifically, the Training and
Mentoring plans will extend the applicant’s methodological expertise to include DNA methylation measures of
biological aging in Veteran populations with PTSD, expanding the applicant’s expertise in using VA EHR health
data, and support the applicant’s long-term career goal of using interventions to improve the health of Veterans
with PTSD. The ongoing mentorship and support the applicant will receive during the CDA-2 award period and
beyond will help his development as a Research Health Scientist at the Durham VAMC.

Public health relevance
Veterans with PTSD are at greater risk of poor health when compared to Veterans without PTSD. One novel mechanism suggested to explain this association is accelerated biological aging. In contrast to chronological aging, which is constant across individuals, people can age faster or slower biologically at the cellular and molecular level. People who are biologically aging faster than others are expected to face more negative health consequences over time, including more chronic disease, disability, and premature mortality. If Veterans with PTSD evidence accelerated aging, it could help explain one way in which PTSD might translate to poorer health. Importantly, behavioral interventions have been shown to prevent accelerated aging. If empirical evidence could point to plausible behavioral mechanisms that are linked to both PTSD and accelerated aging, such mechanisms would present promising intervention targets to improve health among Veterans with PTSD, ideally earlier in the lifespan before the effects of ill health have accumulated.